TYPE IB SECRETORY PHOSPHOLIPASE A2 METABOLISM IN PANCREATIC ISLET B-CELLS

Stimulation of pancreatic islets with D-glucose induces insulin secretion from secretory granules contained within the islet b-cells. D-glucose also induces islet phospholipid hydrolysis and accumulation of non-esterified arachidonate, as demonstrated by isotope dilution mass spectrometry. Accumulating evidence suggests that secretory phospholipases A2 (sPLA2) may play a role in the distal events of secretory processes in many different cell types. Since intact pancreatic islets have been reported to contain sPLA2, it was of interest to determine the cellular and subcellular localization of the sPLA2 enzymes in pancreatic islets. Our findings indicate that rat pancreatic islets express mRNA for both types IB and IIA sPLA2 enzymes and mRNA for an sPLA2 membrane receptor. Immunoblotting analyses with antibodies directed against type IB sPLA2 or against type IIA sPLA2 indicate that the type IB isoform is much more abundant than the type IIA isoform in islets. Studies with p urified populations of islet b-cells prepared from dispersed islet cells by fluorescence-activated cell sorting indicate that both sPLA2 activity and type IB sPLA2 immuno-reactive protein are substantially more abundant in b-cells than in non-b-cells. Subcellular fractionation studies indicate that sPLA2 activity and type IB sPLA2 immuno-reactive protein are contained in insulin secretory granules. Stimulation of intact islets with insulin secretagogues results in the co-secretion of insulin and of sPLA2 activity and type IB sPLA2 immuno-reactive protein into the incubation medium. These findings raise the possibility that type IB sPLA2 participates in the secretory process of pancreatic islet b-cells.